Structural Mechanisms Underlying the Activity Regulation of the Receptor-like Protein Tyrosine Phosphatase, CD148/PTPRJ

ABSTRACT Unchanged from original proposal.

Public health relevance
PROJECT NARATIVE Unchanged from original proposal.